The Hemostasis, Thrombosis, and Inflammation Models Core

Abstract
The Hemostasis, Thrombosis, and Inflammation Models Core (Core A) will provide the resources, equipment
and technical expertise to conduct the in vivo assays that are a critical component of all projects included in this
program.
The main services provided by the core are:
1. Organize shipment of mice from UC San Diego to UNC Chapel Hill and to establish colonies for select strains
at UNC Chapel Hill
2. Subject mice to various models of hemostasis, thrombosis, and inflammation
3. Analyze data and provide project investigators with results and feedback on how to move forward with
projects/ mouse model studies.
Including an animal models core will increase reproducibility in results obtained for the various projects in this
PPG, and drastically reduce costs for labor and set-up/ maintenance of major equipment. Core A will be directed
by Dr. Wolfgang Bergmeier, an Associate Professor of Biochemistry and Biophysics at the University of North
Carolina who has many years of expertise in the use of animal models (Hemostasis, Thrombosis, and
Inflammation) and state-of-the-art intravital microscopy (IVM) imaging techniques. In his own research, he has
made seminal contributions to our understanding of how the small GTPase Rap1 and its regulators affect platelet
and neutrophil functions – a major focus area of this program.